3D RADIAL PIPELINE FOR RECONSTRUCTION OF CLINICAL 129XE IMAGES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We are currently conducting clinical imaging of hyperpolarized 129Xe. Historically we have used multi-slice GRE sequences that reconstruct on the scanner. However, we are now becoming increasingly interested in using radial acquisition and reconstruction for this work. Hence, we are becoming increasingly reliant on the data reconstruction and image archiving pipeline maintained by the CIVM staff. Our ongoing program will be working to produce isotropic 129Xe ventilation images as well as images of 129Xe dissolved in pulmonary blood and tissues. On-going pulse sequence development is also being done to acquire both of these images simultaneously during a single breath hold. This work makes use of the CIVM infrastructure, but should require no further support. This project form is being written to document usage of the CIVM infrastructure and to ensure that a project code is available for reconstructing and archiving xenon images.